Thioredoxin derivatives for radiation mitigation

Escalating geopolitical instability, nuclear proliferation, and vulnerability of medical, radiological and nuclear
power infrastructure are real and constant threats raising the likelihood of catastrophic radiation exposure.
Hematopoietic stem cells (HSCs) and hematopoiesis are among the most sensitive tissues/organs to radiation
injury with multiple organ systems also affected. Since incidents are likely to be unanticipated, therapeutic
strategies need to be effective even if commenced hours or days post-exposure, and administration routes
should be compatible with treatment in the field. Currently, there are very few - if any - agents that can be used
to rescue injury from lethal radiation doses after 24 hours. This gap represents a critical unmet need for both
public health and the armed forces. The human stress-protectant protein thioredoxin (TRX) has shown exciting
potential as a broad-acting radiation protective agent but does not have suitable pharmacological properties
for use as a drug. Preliminary rodent and non-human primate (NHP) studies by the applicant with ORP100S,
an engineered pharmacologically optimized version of TRX, have demonstrated remarkable radiation survival
when ORP100S was administered subcutaneously 24 hours after irradiation. Long-term goal: develop
ORP100S into a “deliverable” agent for treatment of lethal radiation-related injury. Overall objectives: further
define the efficacy of ORP100S in mitigating radiation-induced injury and determine the molecular mechanisms
through which ORP100S regulates and protects HSCs from radiation injury. Central hypothesis: ORP100S has
broad, pan-cytoprotective effects on multi-organ systems and can mitigate lethal dose radiation. These
hypotheses have been formulated based on data produced in the applicant’s laboratory. The rationale for the
proposed research is that, once it is known how ORP100S protects HSCs and its effectiveness is confirmed in
both mice and non-human primates, we will be able to move ORP100S forward into clinical use as a new and
innovative therapeutic for radiation-related injury. Guided by strong preliminary data, this hypothesis will be
tested by pursuing three specific aims: Aim 1: determine the dose modifying factor of ORP100S and ability to
rescue hPSC lung organoids from radiation injury. Efficacy of ORP100S in mitigating lethal radiation will be
compared with the FDA approved agent (G-CSF) and any synergistic effects will be identified. Aim 2: define
the molecular mechanisms through which ORP100S protects HSCs from radiation injury. Effects of ORP100S
on the p53-ferroptosis pathway will be defined. Aim 3: determine efficacy, safety, PK, PD, and cytokine profiling
of ORP100S in mitigating radiation-induced injury in non-human primates. The approach is innovative,
because it focuses on a novel protein that is effective in mitigating toxic effects of radiation when given after
24 hr of radiation exposure. Humanized mouse model and hPSC induced lung organoids will be used and
novel molecular pathway will be investigated. The proposed research is significant, because it will bring a new
therapeutic agent to the national stockpile for the treatment of radiation injury.

Public health relevance
Project Narrative The proposed research is relevant to public health because it addresses one of the real and constant dangers to our public health (i.e., radiation injury). The studies will bring a potentially therapeutic agent to countermeasure this threat and mitigate the effects of radiation injury. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disability.